Development of an Animal Model of Task Specific Dystonia

ABSTRACT
The circuit mechanisms that cause dystonia are poorly understood. A prominent hypothesis is that dystonia is
caused by aberrant plasticity within motor structures, especially cortical-basal ganglia circuits. The lack of a
suitable animal model is a critical barrier to progress. Our preliminary data indicate that we have
developed a strategy to generate the ﬁrst rodent model of human task speciﬁc dystonia by uniquely combining
genetic and behavioral manipulations. This strategy is based on observations suggesting that dystonia requires
“two hits”: a genetic predisposition to abnormal plasticity and a plasticity-inducing environmental trigger (e.g.,
repetition of speciﬁc dexterous movements as with musician's dystonia). We modeled the genetic
predisposition with our established model of DYT1 dystonia, caused by inherited mutation in the gene
encoding torsinA. TorsinA mutant “Dlx-CKO” mice do not show abnormal movements at baseline, but exhibit
selective abnormalities of striatal cholinergic interneurons (ChIs), providing a substrate for striatal dysfunction.
Strikingly, Dlx-CKO mice trained to repetitively perform a dexterous paw reaching task develop
abnormal, phasic, dystonic-like movements. In contrast, these mice do not develop abnormal movements
after repetitively performing a non-dexterous rotarod task. This proposal will focus on establishing the
validity and utility of this long-sought model of dystonia. We hypothesize that abnormal function of ChIs in
the setting of repetitive dexterous limb movements causes abnormal striatal activity which leads to task-
speciﬁc dystonic-like movements in Dlx-CKO mice. We will test this hypothesis with three Speciﬁc Aims. In
Aim 1, we will deﬁne the necessary and sufﬁcient behavioral conditions for these mice to develop abnormal
movements, and attempt to extend our ﬁndings to DYT1 knock-in mice. In Aim 2, we will examine striatal
electrophysiology as these movements develop. In translational Aim 3, we will use chemogenetic technology
to selectively manipulate ChI activity in Dlx-CKO mice to determine whether modulation of this speciﬁc cell type
can suppress dystonic-like movements and to deﬁne the striatal mechanism of these effects. Successful
completion of these Aims will establish a unique model of task speciﬁc dystonia with high construct,
face and predictive validity. This model will exert a powerful impact on the dystonia community by allowing
detailed study of network mechanisms in dystonia and suggesting novel therapeutic approaches. More
generally, this model will improve understanding of normal interactions between extrapyramidal and pyramidal
motor systems, with broad relevance for a range of movement disorders.

Public health relevance
PROJECT NARRATIVE The brain circuitry responsible for abnormal movements in dystonia, an incurable brain disease that manifests as involuntary twisting movements, is poorly understood. We will develop the first mouse model of task specific dystonia, a relatively common form of the disease. Development of this model will enable researchers to productively study this disease, and our proposed initial studies will clarify the role of a specific group of nerve cells in the illness.